Oxytocin and drug extinction in prairie voles

Project Summary/Abstract
Drug abuse is a serious worldwide public health problem [1-3]. While the majority of research has focused on potential
neuropharmacological interventions [2], social connection and social affiliation also have profound effects on drug addiction
[4, 5]. Not only do positive social connection and social interaction prevent and/or reduce drug use and dependence, they
also facilitate drug reward extinction [4]. Unfortunately, studies on the interaction between drug addictive behaviors and
the social environment are limited. This is partially due to the difficulties inherent in studying neurobiological mechanisms
in humans as well as the fact that traditional laboratory rodent species show limited adult attachment behavior [6-8].
Recently, the socially monogamous prairie vole (Microtus ochrogaster) has emerged as an alternate and unique rodent
model for investigating the role of social environment on addictive behaviors. In prairie voles, social bonding between
mating partners (pair bonding) [7, 9] and familiar cage mates (peer bonding) [10, 11] can be tested by using the partner
preference paradigm. The rewarding value of the psychostimulant amphetamine (AMPH) can be assessed in this species
using an established conditioned place preference (CPP) paradigm [12]. Using the combination of those two behavioral
paradigms, interactions between social bonding and AMPH reward have been shown and neurochemicals, such as oxytocin
(OXT) and dopamine have been implicated in regulating such interactions [13-15]. These findings illustrate the utility of
this unique animal model for such investigation [6, 8]. Recently, our data have shown that, in female prairie voles, the
presence of a peer partner facilitates AMPH CPP extinction. This social facilitation of AMPH CPP extinction can be
impaired by the peer partners’ own AMPH experience but rescued by brain administration of OXT. Here we propose to
use the prairie vole model to systematically study the effects of peer partners on facilitating AMPH CPP extinction and the
underlying OXT-mediated mechanisms. Specifically, in Aim 1, we propose to establish and validate the behavioral
paradigms and to characterize the sex differences in, and the impact of the partner’s drug experience on, the social
facilitation of AMPH CPP extinction. In Aims 2 and 3, we will focus on the nucleus accumbens to examine changes in
OXT release and OXT receptor (OXTR) expression associated with AMPH CPP extinction, and then examine how
pharmacological OXTR manipulation or viral-mediated chemogenetic inhibition/activation of OXT pathway activity alter
social facilitation of AMPH CPP extinction. Together, data from this study will not only enhance our understanding of the
social facilitation of drug reward extinction and the potential therapeutically relevant mechanisms that underlie it but will
also further establish a much-needed animal model to investigate the profound effects of social environment on drug
addictive behaviors.

Public health relevance
Project Narrative Positive social affiliation and social interaction can prevent/reduce drug use and dependence and facilitate drug reward extinction. Here, we propose to use the unique socially monogamous prairie vole (Microtus ochrogaster) model to study the effects of peer partners on facilitating amphetamine reward extinction and the underlying oxytocin-mediated neural mechanism. Data from this study will not only enhance our understanding of social facilitation on drug reward extinction and the potential therapeutically-relevant mechanism but also firmly establish a much needed animal model to study drug- and social-reward interaction and its underlying mechanisms.